Developmental Psychopathology and Maternal Substance Use

DESCRIPTION (provided by candidate): A Scientist Development Award for New Minority Faculty is being requested to support five years of career development and research activities in developmental psychopathology (substance use and violence) among African American adolescents of maternal substance users. The K01 will provide 80% release time from an academic appointment at UM-St. Louis to collaborate with a three-mentor panel available locally. The panel and consultants will provide mentoring and consultation in developmentally psychopathology, clinical observation, advanced statistical analysis, the responsible conduct of research, and guided research activities. The career development activities will be enhanced through coursework in developmental psychology and qualitative research, training in assessment of adolescent psychopathology, and workshops specific to adolescent substance use and violence. The K01 fuses two research focal points that have dominated the candidate's research career: substance use and violence in African American adolescents and psychopathology in adult African American female substance users. The purpose of the K01 award is to prepare the candidate for an independent research career in African American adolescent mental health. The goal of research activities is to collect pilot data that will provide the basis for an R01 study that longitudinally examines the intervening role of maternal substance use on adolescent normal or abnormal development. The research will occur in two phases to maximize research and career development experiences. Phase I of the research will qualitatively assess the role of fathers and the extended family network in adolescent development and in the home environment from a sample of adolescents of maternal substance users. Phase II of the research will gather pilot data on 150 African American adolescents (15-17 years of age) of active substance using mothers (and 50 demographically matched comparisons). Mentors and consultants will provide expertise and oversight in all career development and research activities.